CTSA Postdoctoral T32 at The Scripps Research Institute

Project summary
Scripps Research is becoming a leader in the field of translational research. This leadership establishes
itself on three strengths: the quality of its faculty, its outstanding and holistic training programs, and its
interdisciplinary culture. Ours is one of the few institutions in the US where a basic science idea can be
taken seamlessly to a drug candidate and a clinical trial. Reciprocally, we can also bring patients' data
or specimens from the clinic to the most basic aspects of science, including genomics, structural
biology, and chemistry. This translational ability requires early career scientists to be trained across
disciplines and in many emerging areas of data acquisition and processing. These areas include single
cell data acquisition, genomic studies, big data analysis, sophisticated biological measurements, and
animal models, and ultimately a deep knowledge of the disease being studied. In addition to this
interactive scientific multilayered education, our program benefits from our efforts to recruit, include,
retain, and support scientists from underrepresented gender, ethnic, and racial backgrounds.
Involvement in outreach initiatives towards underprivileged communities and patient-based
organizations is a mandatory requirement for our students. Advancing diversity, equity, and inclusion
(DEI) through curricula, training, and expanded recruitment partnerships, will be promoted by dedicated
T32 (one each from predoctoral and postdoctoral cohorts) DEI Liaisons. The DEI liaisons will
communicate directly with the Scripps Research Diversity Advisory Committee and will be involved in
recruitment activities. The probability of success of our efforts is enhanced by the integration of the
post-doctoral training program within the larger educational goals of the Scripps Research CTSA,
including interns, predoctoral students, and clinical research fellows. This mentee to mentor approach
is exemplified by the pairing of each T32 postdoctoral scholar with two T32 predoctoral scholars, and
a K12 scholar, and the T32 trainee summer supervision of interns from the SURF program. This aspect
of our training program will be enhanced by an already existing mentorship structure and an added
mentor training program. Our T32 funding will support three T32 postdoctoral trainees for 2-3 years
and will train them for a successful career in translational science and medicine. A particular emphasis
will be put on individual grant writing and submission to establish research independence. Translational
science coursework, created and directed by SRTI research team leaders, will incorporate protocol
design, literature review, ethical research practice, transdisciplinary teamwork, effective
communication, and advanced translational methodologies.

Public health relevance
The T32 postdoctoral training program of the Scripps Research CTSA aims to establish a new generation of early career scientists capable of bridging science and medicine in the context of a rapidly changing world of healthcare and emerging diseases. Basic science, elucidation of mechanisms of diseases, discovery of new therapeutic approaches and drugs, and digital monitoring of health are primary areas of investigation for our members. In addition, an important component of citizenship is included in our training to promote three important core competencies: (i) mentorship, (ii) inclusion of all groups regardless of gender, racial, and cultural backgrounds, and (iii) community engagement.